DOSE REGIMEN STUDY FOR GPA 748 IN GROWTH HORMONE DEFICIENT ADULTS

The purpose of this phase II clinical trial is to evaluate the safety and pharmacodynamic responses of growth hormone, IGF-1, and IGF-GP3 to three different multiple, oral dose regimens of GPA-748 in growth hormone deficient adults.